Developing a Dyadic Survivorship Intervention for Black Women with Breast Cancer and Their Informal Caregivers

1 Breast cancer patients and their informal caregivers often report unmet psychosocial, relational, and physical
2 health needs that persist into long-term survivorship. Although dyadic interventions have shown promise in
3 improving outcomes for patients and caregivers, few existing interventions are designed for Black patients and
4 the female family members and friends who provide the majority of unpaid care and support. This study will
5 develop a novel dyadic intervention delivered via video teleconferencing (VTC) to Black breast cancer patients
6 and their female informal caregivers to improve quality of life and relationship outcomes during the transition to
7 long-term survivorship. This proposal is directly responsive to NCI’s priorities about caregiving and cancer
8 survivorship and will lay the foundation for a randomized controlled trial of a first-of-its-kind dyadic intervention.
9 First, we will build on our previous and current work with Black breast cancer patients and their informal
10 caregivers by asking dyads to evaluate potential intervention content. Next, we will design for dissemination by
11 interviewing stakeholders to identify facilitators and barriers to implementing dyadic survivorship interventions
12 in clinical care. Finally, we will develop a brief intervention and evaluate its acceptability and feasibility. The
13 aims of this proposal are as follows: Aim 1: Evaluate the potential domains and characteristics of a brief
14 VTC intervention to improve quality of life for Black breast cancer patients and female informal
15 caregivers during the transition to long-term survivorship. We will solicit qualitative and quantitative
16 feedback from both members of dyads individually and together (N = 20 dyads) about themes, domains, and
17 characteristics of a culturally appropriate patient- and caregiver-centered VTC survivorship intervention. Aim 2.
18 Identify facilitators and barriers to implementing dyadic survivorship interventions in clinical care. We
19 will design for dissemination by conducting interviews (N = 15) with stakeholders the cancer center based on
20 the Consolidated Framework for Implementation Research. A directed thematic analysis will allow us to
21 understand barriers and facilitators to delivering dyadic interventions in clinical care. Aim 3. Evaluate a brief
22 VTC intervention in a pilot feasibility study (N = 20 dyads). Based on the formative research in Aims 1 and
23 2, we will develop a 4-session intervention delivered remotely by psychology service staff at the cancer center
24 around the time patients complete active treatment and transition to long-term survivorship. We will collect
25 quantitative and qualitative feasibility data from patients and their female caregivers about satisfaction and
26 intervention acceptability. We will also pilot test the assessment battery, including validated measures of
27 relationship outcomes, health care utilization, and quality of life for both dyad members. Upon completion of
28 this project, our team will be well-positioned to test the intervention in a larger trial. The ultimate goal of this
29 research program is to reduce health disparities by improving outcomes for Black breast cancer patients and
30 their female caregivers.

Public health relevance
PROJECT NARRATIVE Breast cancer patients and their informal caregivers often report unmet psychosocial, relational, and physical health needs that persist into long-term survivorship. Although dyadic interventions have shown promise in improving outcomes for patients and caregivers, few interventions are designed for Black patients and the female friends and family who provide them with support and care. This study will develop a novel dyadic intervention delivered via video teleconferencing to Black breast cancer patients and their female caregivers to improve quality of life during the transition to long-term survivorship.